Administrative Supplement for the Coordinating Center for the Breast Cancer and the Environment Research Program

No change from original proposal.

Public health relevance
No change from original proposal.